BORRELIA BURGDORFERI STIMULATES PRODUCTION OF PRO &ANTI INFLAMMATORY CYTOKINES

Background and Objectives We have shown that when peripheral blood mononuclear cells (PBMC) from both normal humans and rhesus monkeys were co-incubated with either heat-killed B. burgdorferi or purified OspA lipoprotein, the PBMC transcribe and secrete IL 10 (an anti-inflammatory cytokine). The objectives of this research is to determine the cell type among the PBMC that is responsible for the induction of the IL-10 cytokine gene. Normal human PBMC were stimulated with heat-killed JD1 spirochetes and then separated into T cells, B cells and monocytes using immunomagnetic beads linked to appropiate antibodies. Results We show that monocytes but not T or B cells are the cells that transcribe IL-10 in response to the spirochetes. In addition, we also show that IL-1 and IL-6, two pro-inflammatory cytokines, are produced by monocytes when stimulated with heat-killed JD1 spirochetes. After determining that the PBMC cell type that secreted IL-10 in response to heat killed-JD1 spirochetes was the monocyte, experiments were performed with the human monocytic cell line THP-1. B. burgdorferi spirochetes induced the production of IL-10 and IL-6 in culture supernatants of this cell line in a dose dependent fashion. THP-1 cells also responded to the OspA lipoprotein by producing both IL-6 and IL-10 cytokines. The response to lipidated OspA (L-OspA), measured as the concentration of either IL-6 or IL-10 in the cell supernatant, was dose dependent and was unaffected by the presence of 10 fg/ml of polymyxin B, an inhibitor of LPS stimulation. No response was measurable when cells were incubated in RPMI medium without additions or with added unlipidated OspA (U-OspA) or U-OspC. These results suggest that a dynamic balance between pro- and anti-inflammatory responses that are elicited by the same cell population in response to spirochetal lipoproteins could play a role in the pathology of Lyme disease, in particular the transient and recurrent nature of the disease's inflammatory episodes. Future Directions To use the THP-1 cell line as a model for monocytes that are contained in PBMC of humans and nonhuman primates to study